Learn from the Errors at the Start of Life: Dissect Cellular Fitness Through Dynamics of Chromosomal Instability in Embryogenesis

Project Summary
Chromosomal instability (CIN), characterized by changes in chromosome number and structure, leads to
aneuploidy (abnormal chromosome numbers) and copy number variations (CNVs), where specific genomic
regions are duplicated or deleted. Although often considered a hallmark of tumor transformation and cancer, CIN
is also surprisingly prevalent in human embryos from the first cleavage event. These initial divisions are directed
by maternal machinery pre-loaded into oocytes before genome activation, making early embryogenesis
particularly prone to errors, resulting in a high prevalence of mosaicism. Some embryos with both normal and
aneuploid cells develop to term by selectively eliminating abnormal cells, suggesting robust elimination
mechanisms that favor euploid cells through differentiation and selective apoptosis of aneuploid cells.
While CIN in cancer has been intensively studied, the mechanisms of CIN progression and tolerance in tumor
cells remain poorly understood. This gap is even more pronounced in early development due to ethical and
technical challenges in studying human embryos and fetuses, and the lack of suitable model systems to examine
chromosomal and cellular phenotypes. The remarkable resilience of embryos to chaotic chromosomal events
highlights embryogenesis as a unique platform for understanding cell-type specific and context-dependent
cellular fitness.
Leveraging stem cell and organoid techniques with state-of-the-art genomic and imaging tools, the proposed
study aims to establish a unique, controllable, and easily modulated in vitro model system using the embryonic
and extraembryonic stem cell lines we have developed to capture embryogenesis traits and reflect CIN status.
The study will address three main questions: 1. Cell type-dependent intrinsic mechanisms of CIN tolerance and
suppression reflected in stage-specific stem cell lines will be uncovered through CNV-revealing single-cell multi-
omics and modulated through high-throughput genomic tools. 2. Context-dependent cell competition will be
dissected to explore modulation strategies targeting specific pathways, including p53, Myc, and Hippo, as well
as identified non-canonical cell competition pathways. 3. Non-cell-autonomous environmental cues in the uterus
that affect and constrain CIN will be investigated through a unique co-culture system with endometrial organoids.
This research opens new avenues for studying cellular fitness in the context of CIN. The information gained will
pave the way for therapeutic innovations that harness the body’s own mechanisms to correct chromosomal
imbalances, potentially leading to advancements in enhancing embryo viability. Additionally, through these
innovative strategies, I aim to develop comprehensive and powerful new methodologies that could be applicable
to studying other CIN-affected disease or condition prognosis.

Public health relevance
Project Narrative Chromosomal instability (CIN), characterized by changes in chromosome number and structure, is often considered a hallmark of tumor transformation and cancer, yet is also surprisingly prevalent in human embryos from the first cleavage event. The remarkable resilience of embryos to these chaotic chromosomal events highlights embryogenesis as a unique platform for understanding cell-type specific and context-dependent cellular fitness. The aim of this proposal is to establish a unique model system using embryonic and extraembryonic stem cells to understand the intrinsic and extrinsic mechanisms involved in CIN during embryogenesis, with the ultimate goal of modulating CIN tolerance for potential therapeutic advancements.